RECOMBINANT CD4 IN CHILDREN WITH HUMAN IMMUNODEFICIENCY VIRUS INFECTION

The purpose of this study is to assess the safety pharmacokinetic properties of RCD4 in infants and children infected with or at risk for human immunodeficiency virus (HIV) infection.